Deciphering the Transcriptomic Basis of Chemo Fog

PROJECT SUMMARY/ABSTRACT
CANDIDATE: My long-term career objective is to lead an independent research program dedicated to improving
the efficacy of cancer treatments and the post-treatment experiences of cancer survivors. This proposed
research represents a convergence of my research experiences: to elucidate the transcriptional mechanisms
underpinning cognitive impairment induced by cancer therapies, a critical issue affecting cancer survivors. In
preparation for this transition to independence, I have curated a training plan encompassing four key objectives:
(1) acquiring essential skills, (2) forging strategic scientific collaborations, (3) honing professional development,
and (4) ensuring a seamless transition to independence. This proposal serves as a blueprint for my future
research career in the field of cancer biology. RESEARCH: Chemotherapy, despite its life-saving potential, often
leads to debilitating side effects such as cognitive impairment, significantly diminishing the quality of life for
cancer survivors. Multiple studies have identified disturbances in brain cell homeostasis upon chemotherapy
treatment, including neuronal death, disrupted myelination, and activated microglia. However, the transcriptional
regulation governing these changes remains largely unclear. My early postdoctoral research revealed substantial
transcriptional overlaps shared among various forms of cognitive impairment, including aging, Alzheimer's
disease, and severe COVID-19. Yet, whether this transcriptional overlap, and more crucially, its regulatory
mechanisms, extend to chemotherapy-induced cognitive impairment (CICI) remains unknown. Through
comparative analysis of brain transcriptomic profiles of mice upon systemic chemotherapy treatment and other
forms of cognitive impairment, I have identified candidate transcription factor drivers of CICI. This proposal will
test the hypothesis that transcriptomic states (Aim 1) and key underlying transcription factor regulators (Aim 2)
can be manipulated to modify CICI behaviors in mice (Aim 3). These investigations will illuminate the
transcriptional underpinnings of cognitive impairment induced by chemotherapy, offering new insights into
potential therapeutic strategies to ameliorate or reverse this debilitating side effect. ENVIRONMENT: The
Harvard Medical School community provides an optimal setting for me to achieve my training and research
objectives while successfully transitioning to an independent faculty position. My mentors, Dr. Frank Slack and
Dr. Clifford Woolf, are global leaders in RNA biology and neuroscience, respectively. Additionally, I have
assembled an advisory committee comprising three established scientists—Drs. Rosalind Segal, Winston Hide,
and Marcia Haigis—with pertinent expertise and strong commitment to mentorship. Their support will be
invaluable in guiding my research endeavors and facilitating my path toward independence. Combined with the
intellectually rich and resource-abundant communities of BIDMC and BCH, this mentorship team will foster an
ideal environment, enabling me to effectively execute the proposed research and transition to independence.

Public health relevance
PROJECT NARRATIVE Although chemotherapy dramatically improves cancer survival rates, treatment side effects such as cognitive impairment can greatly diminish the quality of life of cancer survivors. This project aims to test whether perturbing key transcriptional regulators in the brain modifies cognitive decline observed upon chemotherapy treatment. The findings of this work will motivate the development of interventions to protect cancer survivors against chemotherapy-induced cognitive decline.